Design and directed evolution of an 'Edmanase' enzyme for high-throughput peptide sequencing

PROJECT SUMMARY/ABSTRACT Significance: Next generation sequencing (NGS) has has transformed the field of genomics and enabled broad adoption of the technology in biological, translational, and most recently clinical research. The proteomics equivalent to NGS has not yet been realized. As such, the goal of this proposal is to develop an innovative and highly-scalable digital peptide sequencing platform to effectively scale and democratize protein analysis by providing a simple robust workflow generating massively parallel peptide sequencing information. Approach: We propose to develop a single molecule digital peptide sequencing platform, using a novel enzymatic cyclic degradation scheme, paralleling Edman degradation except using mild enzymatic steps rather than harsh chemical reagents. Our assay is comprised of several key technology elements: a population of DNA tagged single molecule peptides on beads; N-terminal amino acid (NTAA) labeling with PITC (Edman chemical agent), binding of NTAA recognition agents labeled with DNA encoding tags, writing of the DNA code to a library element attached to the peptide, and enzymatic removal of a single modified NTAA using an engineered Edmanase (the deliverable of this proposal). This assay is cycled for a dozen or more times to generate a DNA library representing peptide sequence information on millions to billions of peptides that is sequenced on a standard NGS instrument. Public Health Impact: In summary, we believe our Next-Gen peptide sequencing assay usher in the era of “next gen proteomics” effectively transforming biological, translational, and clinical research, much like NGS technology has already done in the genomics space.

Public health relevance
NARRATIVE (and OVERALL IMPACT) We propose to develop an innovative and highly-scalable digital peptide sequencing platform that reverse translates protein information into DNA library elements sequencable on a standard Next-Generation Sequencing instrument. Our assay is democratizing and intrinsically scalable enabling the parallel readout of million to billions of peptides in a single run. As such, we believe these features will effectively scale and democratize proteomics assays in the research, translational, clinical, and drug discovery arenas by providing true next generation protein workflows and instrumentation